Training Program in Environmental Toxicology

Project Summary
Funds are requested to support eight predoctoral (Ph.D. candidates) and six postdoctoral trainees in the
Training Program in Environmental Toxicology, a long-standing research training program in molecular
toxicology at Vanderbilt University. This interdisciplinary program provides research career training
in molecular aspects of toxicology related to environmental health. Because the field is inherently
interdisciplinary, research training in the program spans chemistry, biochemistry, chemical biology, structural
biology, analytical technology, microphysiological systems, functional genomics, pathogen-host interactions,
disease pathology, and exposure science. The faculty preceptors have appointments in the departments of
Biochemistry, Biological Sciences, Biomedical Informatics, Chemistry, Medicine, Pathology, Microbiology &
Immunology, Obstetrics & Gynecology, Pediatrics and Physics all of whom have trained doctoral students and
postdoctoral fellows. Training is achieved through basic and specialized coursework, research rotations,
dissertation research, and participation in seminars, journal clubs, and joint research meetings. A distinctive
feature of the program is hands-on training on diverse technology platforms through a highly developed and
open system of research facility cores at Vanderbilt. A fraction of our graduate students are recruited through
specific departments, while most matriculate through one of two umbrella programs: the Interdisciplinary
Graduate Program in Biomedical and Biological Sciences (IGP) or the Quantitative and Chemical Biology
Program (QCB). The students then spend their first 9 months in a common core curriculum and do laboratory
rotations. Graduate students are supported for the first year by these programs or departments. Students then
are recruited into the Training Program in Environmental Toxicology from these first-year pools, and training
program support begins in the second year. Both predoctoral and postdoctoral trainees are selected by the
Training Program Executive Committee composed of the Director, Associate Director and the Internal Advisory
Committee, with guidelines to ensure distribution of trainees and monitoring of progress. The list of preceptors
includes 17 faculty with diverse research interests and substantively well support research programs with the
average current year direct costs available being over $1 million per investigators. Major research areas
represented by our faculty preceptors include (1) Xenobiotic metabolism, detoxication, and enzymology; (2)
Oxidative stress and inflammation; (3) DNA damage, genome maintenance, and replication; (4) Translational
toxicology; (5) Host-pathogen-environment interactions; (6) Systems biology and developmental toxicology;
and newly represented this cycle (7) Organs-on-chips and microphysiological systems. Graduates from the
program have been highly successful in academia, industry, and other professional settings and include
leaders in the field.

Public health relevance
Project Narrative This interdisciplinary program has a long-standing and successful history of training scientists for careers in molecular toxicology as applied to environmental health. Our trainees have gone on to productive careers in academia, industry, and government institutes. Trainees receive a strong, broad background in basic science with opportunities to specialize in specific subdisciplines of basic and translational research.